Targeting MED31-driven transcription recycling in lethal prostate cancer

Project Summary/Abstract
Patients with lethal castration-resistant prostate cancer (CRPC) are currently treated with agents targeting
androgen receptor (AR) signaling. However, AR inhibition has not dramatically improved CRPC patient survival,
underscoring the need to discover novel oncogenic mechanisms in CRPC and develop new therapies targeting
these mechanisms. Cancer cells are addicted to aberrant RNA polymerase II (Pol II) transcription, which includes
initiation, elongation, and termination phases, as well as a recycling step critical to repeated Pol II transcription
of the same gene after the initial transcription cycle. While studies have already indicated that uncontrolled
transcriptional initiation and elongation have oncogenic roles, it is unknown whether other Pol II transcription
processes contribute to cancer-relevant transcriptional outcomes and cancer growth. In preliminary studies, our
newly developed in vitro and cell-based transcription recycling assays have found that Pol II recycling is a key
yet overlooked transcription process with relevance to prostate cancer. We have found that Mediator complex
subunit 31 (MED31) drives Pol II recycling in CRPC cells, enhancing mRNA output during the recycling process.
Importantly, high expression of MED31 is both sufficient and necessary for prostate cancer castration-resistant
growth and is associated with poor prognosis of CRPC patients. While these findings identify the oncogenic
MED31 as a new therapeutic target for CRPC, transcription regulators such as MED31 are generally considered
untargetable by traditional, small molecule-based drug design. We have developed a safe lipid nanoparticle
(LNP) system for targeted delivery of the CRISPR/Cas13d system to efficiently and specifically knock down
oncogenic transcription regulators at the mRNA level. In preliminary studies, we have demonstrated that the
LNP-Cas13d system effectively and safely knocks down MED31 mRNA and decreases CRPC cell growth in vivo,
establishing the proof of the concept that the therapeutic window exists for targeting MED31 in CRPC. Together,
our preliminary findings support the hypothesis that MED31-governed transcription recycling is a novel
oncogenic driver for CRPC progression and that an LNP-Cas13d-based RNA targeting system can counteract
oncogenic transcription driven by MED31 in CRPC with safety, specificity, and efficacy. In Aim 1, we will delineate
the molecular mechanism, biological function, and clinical relevance of MED31-mediated transcription recycling.
In Aim 2, we will target MED31-mediated transcription recycling using a CRISPR/Cas13d-based nanoparticle
system. The successful completion of these aims will significantly elucidate the critical role of Pol II recycling in
lethal prostate cancer and will provide an experimental basis for future clinical trials testing the utility of an LNP-
Cas13d RNA targeting system to target this novel oncogenic mechanism in CRPC patients.

Public health relevance
Project Narrative The proposed studies will discover MED31-driven transcription recycling as a novel oncogenic mechanism contributing to progression of lethal castration-resistant prostate cancer (CRPC). Our studies will yield detailed molecular insight into the control of aberrant transcription recycling in lethal prostate cancer, while performing preclinical development of a CRISPR/Cas13d RNA targeting-based nanotherapy targeting MED31-mediated transcription recycling in CRPC.